Novel non-genotoxic ligand-based CD117-directed CAR T conditioning in the context of hematopoietic stem cell transplantation and leukemia treatment

PROJECT SUMMARY
It is essential to study improved therapies for the treatment of advanced acute myeloid leukemia (AML), as nearly
30% of children will relapse or have refractory disease, bringing the survival down to a mere 20%. Hematopoietic
stem cell transplantation (HSCT) is curative for relapsed AML; however, the genotoxicity of bone marrow (BM)
conditioning represents a substantial barrier in its use. Current BM conditioning regimens consist of a
combination of alkylating chemotherapeutic agents such as busulfan and high doses of total body irradiation
(TBI). Similar to the non-targeted chemotherapeutics used as first-line treatment for AML, these conditioning
agents are also highly genotoxic and have several harmful toxicities outside of the hematopoietic compartment,
such as organ failure and secondary malignancies. In contrast, cellular therapies provide strong support for the
use of targeted therapies in the relapsed setting, as evident by five total FDA approved chimeric antigen receptor
(CAR) products for the treatment of relapsed cancers, three of which have been approved within the last year.
Therefore, we hypothesize that the development of non-genotoxic conditioning regimens that specifically target
hematopoietic stem cells (HSCs) and AML will be transformative to the treatment of the disease. The use of c-
kit (CD117) as a target for non-genotoxic conditioning has been explored by our lab and others due to its
expression on HSCs. Up to 90% of AML patients have c-kit expression, and this expression correlates with poor
prognosis and resistance to chemotherapy. We hypothesize that specifically targeting c-kit for AML treatment
will reduce tumor burden in addition to serving as a non-genotoxic conditioning regimen prior to HSCT. This
proposal seeks to explore a novel ligand-based c-kit directed CAR (SCF CAR) to target HSCs (Specific Aim 1)
and AML (Specific Aim 2) by utilizing the c-kit receptor’s natural ligand stem cell factor (SCF) as the recombinant
antigen binding domain of our CAR. Importantly, ligands offer a greater understanding of receptor-ligand
interactions and can potentially reduce tonic CAR signaling through enhanced protein stability, leading to less T
cell exhaustion, among other key advantages. Furthermore, our lab has optimized the use of γδ T cells as a
cytotoxic alternative to ⍺β T cells. γδ T cells are uniquely beneficial for this setting since they i) are innate immune
cells that do not form memory T cell phenotypes to the same extent as ⍺β T cells, ii) do not cause graft-vs-host
disease (GvHD) when transplanted across major histocompatibility (MHC) barriers, iii) contribute to the innate
killing of leukemia cells via graft-vs-leukemia (GvL) interactions, as γδ T cells can recognize cancer cell stress
antigens, and iv) have been shown to enhance survival and decrease leukemia relapse post-HSCT. We therefore
propose utilizing the cytotoxic abilities of γδ T cells to capitalize on these effects, as our lab has optimized the
ex vivo expansion and modification of γδ T cells via the development of a serum-free protocol, making our lab
uniquely suited to perform these experiments. Our goal is to advance the use of CAR T therapy to patients with
AML and to elucidate the broader application of a combination cancer and bone marrow conditioning treatment.

Public health relevance
PROJECT NARRATIVE Approximately 30% of children with acute myeloid leukemia (AML) will relapse following first-line chemotherapy, bringing the survival down to a mere 20% with hematopoietic stem cell transplantation as a final hope for cure. However, both first-line chemotherapy and the pre-transplant conditioning regimen required prior to transplantation have many detrimental side effects, such as infertility and secondary malignancies. Therefore, it is essential to study targeted conditioning regimens and treatments for AML to ultimately enhance treatment conditions and improve the chance for cure via stem cell transplantation.